Sexual dimorphism of piRNA transcription and target silencing mechanisms in C. elegans

Abstract
The Piwi-interacting RNA (piRNA) pathway promotes animal fertility by protecting the germline genome against
mobile DNA elements. Despite this well-established paradigm, several critical gaps remain in our understanding
of piRNA mechanisms, including the sexual dimorphism of their biogenesis and downstream gene regulatory
functions. We discovered that the ancient SNAPc (or SNPC) transcription complex that transcribes small nuclear
RNAs (snRNAs) of the spliceosome has diversified in C. elegans to drive the expression of male- and female-
specific piRNAs, in addition to its canonical function in snRNA transcription. In the fly and human, the SNPC
holocomplex is composed of SNPC-1, SNPC-3, and SNPC-4 subunits, each encoded by a single gene. In
contrast, C. elegans expresses several paralogs of SNPC-1 and SNPC-3 that we propose dictate the specificity
of three distinct SNPC complexes. In particular, based on our published and preliminary data, we hypothesize
that the SNPC-1 paralogs comprise the primary specificity factors that define the unique functions of each SNPC
complex for either snRNA or sex-specific piRNA transcription. In this proposal, we will first investigate how this
specificity is achieved by identifying the cis-regulatory elements recognized by each SNPC transcription complex
(Aim 1). We will also determine the specificity domains, cofactors, and subcellular assembly of the piRNA and
snRNA SNPC complexes (Aim 2). Finally, we will characterize the biological phenotypes of the male and female
piRNA mutants and leverage these insights to predict and validate endogenous gene targets of sex-specific
piRNAs. Collectively, this research will bridge the gaps in our understanding of sexual dimorphism in piRNA
transcription and gene targeting mechanisms that ensure proper germline development and robust reproductive
capacity of animals.
1

Public health relevance
Project Narrative We have discovered that distinct PIWI-interacting RNA (piRNA) transcription complexes drive expression of male- and female-specific germline piRNAs. The goal of this proposal is to understand the mechanisms by which sex-specific piRNAs are expressed and regulate endogenous germline genes. We will characterize the distinct male and female piRNA transcription complexes and elucidate the impact that sex-specific piRNAs have on animal fertility, thus providing insights into therapeutic opportunities for human infertility.